Investigating the Cell Type- and Receptor-Specific Effects of Erythropoietin that Mediate Erythropoiesis and Thrombopoiesis in Primary Human Hematopoietic Progenitor Cells

Chronic kidney disease (CKD) affects 37 million adults in the United States and results in anemia in more than 5 million
patients. Patients with anemia due to CKD often require transfusion or pharmaceutical intervention to combat fatigue and
hypoxia. The most common pharmaceutical intervention is injection of Erythropoietin (EPO), a cytokine that is produced
in the healthy kidney in response to hypoxia. EPO promotes erythropoiesis by enhancing the survival and proliferation of
erythroid-committed progenitors in the bone marrow. However, pharmaceutical EPO administration can cause
thrombocytosis with an increased risk of stroke. This off-target consequence highlights an understudied role for EPO in
non-erythroid-committed cell types and emphasizes the need for further research to clarify the effect of EPO on
hematopoietic progenitors such as the Megakaryocytic-Erythroid bipotent progenitor and Megakaryocytic-committed
progenitor. Furthermore, the receptors and downstream signaling pathways activated by EPO have not been fully
elucidated in subpopulations of hematopoietic progenitors. Our preliminary results indicate that EPO supports survival
and self-renewal of MEP. The research proposed in this application will investigate the cell-autonomous effects of EPO on
bipotent human Megakaryocytic-Erythroid progenitors, Megakaryocytic-committed progenitors, and Erythroid-
committed progenitors ex vivo by measuring activation of signaling mediators, transcriptional expression, and phenotypic
changes. It will also clarify the receptors and targets that are activated in response to EPO signaling in defined
hematopoietic subpopulations utilizing novel receptor-specific EPO mimetics. We hypothesize that in response to EPO,
Megakaryocytic-Erythroid progenitors expand to increase the pool of progenitors capable of giving rise to erythroid and
platelet-producing megakaryocytes, resulting in increased production of both platelets and red blood cells. Successful
completion of these studies will resolve the molecular mechanism of the action of EPO on specific populations of cells in
the bone marrow, which will aid in the development of more targeted and effective therapies for patients with chronic
anemia.

Public health relevance
Project Narrative: The erythropoietic and prothrombotic effects of Erythropoietin in anemic patients implicates the Megakaryocytic- Erythroid progenitor as a direct target, and a useful model to explore mechanisms that uncouple the production of erythroid and platelet-producing megakaryocytic cells. This application describes a small, discrete, well-defined project to identify candidate proteins and target genes that propagate phenotypic and functional changes downstream of Erythropoietin signaling in human hematopoietic progenitors destined to give rise to erythrocytes and platelets. Results from the proposed studies will improve our understanding of the mechanisms of action of Erythropoietin in human bone marrow leading to advancements in treatments for anemia, and will support the lab during transition to independence by generating preliminary data for a future R01 application.